Mechanisms of right ventricle adaptation to pulmonary hypertension

This renewal proposal builds on the scientific premise that even though right ventricle (RV) function and female
sex are major determinants of survival in pulmonary hypertension (PH), no RV-specific or sex steroid-directed
therapies exist. While it is known that macrophage NLRP3 inflammasome activation leads to RV failure, we now
demonstrate for the first time that the NLRP3 inflammasome is also active in RVCMs to promote contractile
dysfunction. The goal of this proposal is to identify novel and therapeutically targetable mechanisms by which
the female sex steroid 17b-estradiol (E2), via its receptor ERα, inhibits NLRP3 inflammasome activation in
RVCMs to enhance contractile function and improve RV-pulmonary artery (PA) coupling. We put forward the
novel hypothesis that RVCM NLRP3 inflammasome activation is sexually dimorphic, and that ERα improves RV-
PA coupling in PH by inhibiting RVCM NLRP3 activation and preventing inflammasome-mediated RVCM
contractile dysfunction. We propose the following specific aims: 1) To identify sexual dimorphisms in RVCM
NLRP3 inflammasome activation and downstream signaling as mediators of sex differences in RV adaptation
and RV-PA coupling; 2) To establish that E2 inhibits RVCM NLRP3 inflammasome activation via ERα; and 3)
To establish NLRP3 inflammasome inhibition as a therapeutic strategy to improve RV-PA coupling in RV failure
in low endogenous estrogen states. We will employ rat models for comprehensive in vivo and ex vivo studies,
complement these studies with mechanistic experiments in isolated primary rats RVCMs as well as in human
chambered muscle pumps generated with inducible pluripotent stem cell-derived cardiomyocytes (iPSC-CMs)
exposed to pressure overload, and validate our findings in RV tissue from PH patients. Endpoints investigated
will include RV function and structure, exercise capacity, NLRP3 signaling, contractile signaling, as well as
ATAC-seq followed by transcription factor enrichment analysis (TFEA). Contractile function will be assessed by
pressure volume loops and echocardiography, an isolated perfused heart model, and by measuring contractility
in iPSC-CMs and RVCMs. The proposed studies are significant, because they will 1) identify NLRP3 signaling
as a sexually dimorphic modulator of RV function that is mediating RV resilience in pre-menopausal females, 2)
establish a novel and therapeutically targetable ERα-NLRP3-calcium signaling axis in the RV, and 3) establish
optimal strategies and conditions to inhibit NLRP3 in the RV-PA unit. Conceptual innovation is provided by
identification of RVCM NLRP3 inflammasome activation as a novel, sexually dimorphic, and ERα-regulated
modifier of RV adaptation in PH. Technical innovation is provided by use of 1) human chambered muscle pumps
generated with iPSC-CMs, 2) ATAC-seq with TFEA in RVCMs, 3) novel and highly selective NLRP3 inhibitors,
and 4) a large animal model of RVF. Upon completion of the proposed studies, we will have established sexual
dimorphisms in RV NLRP3 inflammasome activation as a mediator of sex differences in RV adaptation in PH,
and identified NLRP3 inflammasome inhibition as a novel mechanism of ERα-mediated RV protection in PH.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will determine the underlying mechanisms of how estrogen receptor α improves right heart function in pulmonary hypertension, a progressive cardiopulmonary disease that is caused by thickening of the blood vessels of the lung and that leads to premature death from right heart failure. No cure for pulmonary hypertension is available, and no specific therapies for right heart failure exist. The proposed work is relevant to the mission of the NHLBI, since it will lead to the development of novel treatments for both male and female patients with right heart failure from pulmonary hypertension or other cardiopulmonary diseases.